Hypertensive Disorders of Pregnancy – The Black/White Disparity

Project Abstract
The United States (US) has one of the highest maternal mortality rates in the developed world. Hypertensive
disorders of pregnancy (HDP) such as gestational hypertension, preeclampsia, and eclampsia are major
contributors to maternal mortality and morbidity, complicating approximately 2% to 8% of all pregnancies. In the
US, Black women have disproportionately higher rates of HDP and are almost four times more likely to die from
HDP compared to White women. Urgent action is required to address this racial disparity in HDP and lower the
maternal mortality rate. While traditional cardiovascular risk factors are important contributors to HDP, social
determinants of health (SDOH) have been identified as a fundamental cause of disease and health disparities,
acting at multiple levels of influence. Yet, few studies go beyond the individual level to examine how SDOH,
particularly multi-level products of structures and systems, contribute to the substantial racial gap in HDP. To
address this need, I will identify contributors to HDP disparities using the socio-ecological framework.
Specifically, this proposal will determine whether neighborhood-level racial residential segregation,
interpersonal-level perceived discrimination, and individual-level pre-pregnancy CVD risk factors contribute to or
explain the observed Black-White disparity in HDP. This multi-level research model considers the complex
interplay between individual, community, and societal factors providing a comprehensive approach to
understanding the etiology of HDP disparities. To do this work, I will leverage data from the Coronary Artery Risk
Development in Young Adults study, a prospective cohort study of 5,114 Black and White adults
(nBlackWomen=1480; nWhiteWomen =1307), age 18-30 in 1985 and followed for over 30 years. In aim 1 (neighborhood),
I will determine whether racial residential segregation is associated with incident HDP among Black parous
women. In aim 2 (interpersonal), I will determine whether perceived racial discrimination in the medical care
setting is associated with incident HDP and whether it contributes to the Black-White disparity in HDP. In aim 3
(individual), I will determine whether pre-pregnancy CVD risk factors (defined by the American Heart
Association’s Life’s Essential 8) are associated with incident HDP and whether these factors contribute to the
Black-White disparity in HDP. These aims are embedded within a training plan designed to build my competence
in epidemiology and health disparities research while facilitating my success as a physician-scientist specializing
in women’s health. Identifying reasons for the disparities in HDP is fundamental to develop targeted and effective
interventions to close the racial gap and improve maternal care in the US. This proposal will therefore address
a critical and emergent public health priority to reduce maternal mortality, particularly among Black women.

Public health relevance
Project Narrative Hypertensive disorders of pregnancy (HDP) are a leading contributor of maternal mortality in the US, and Black compared with White women are three to four times more likely to die from HDP. The proposed study addresses an urgent public health issue by investigating individual, interpersonal and neighborhood factors as contributors to the racial disparity in HDP. Results of this study will support the development of strategic interventions targeted to promote health equity and the improvement of birthing outcomes for Black women.